Extended-Release Formulation of Mas Receptor Agonists as Novel Therapeutics for Treating Cognitive Impairment in Patients at-risk forAlzheimer's Disease-Related Dementias and Vascular Dementia

Vascular contributions to cognitive impairment and dementia (VCID) and Alzheimer’s disease related dementias
(ADRD) significantly contribute to the 47 million people world-wide who suffer with dementia. This number is
estimated to increase to over 130 million people by 2050. Several studies have shown that VCID and conversion
to ADRD are strongly correlated with vascular disease, inflammation and decreased cerebral brain blood flow.
The relationship between vascular disease, cognitive function and progression to dementia and possible AD
have been recently reviewed 1. These authors successfully make the case for a close relationship between
cardiovascular risk factors and risk for VCID and ADRD. Furthermore, conversion rates of VCID to dementia
has been reported to be within 40-46% within 5 years of diagnosis of VCID. To date, there are no approved
therapies for VCID. ProNeurogen has been working to develop novel Angiotensin 1-7 (Ang-1–7) formulations to
treat cognitive impairment in patients at for risk ADRD and VCID. The goal of the present SBIR Phase I project
is to advance the development of extended-release (ER) subcutaneous injection formulation for the
administration of our novel peptide therapy, PNA5, for VCID. These novel peptide formulations are designed
to act on Mas receptors (MasR) within the brain vascular endothelium, neuronal cells and microglia to decrease
brain reactive oxygen (ROS) production and neuroinflammation. We have begun to translate these preclinical
findings into novel peptide therapeutics to treat cognitive impairment in patients with heart disease who are at
risk for ADRD or VCID. With support from NIA, we are currently completing our formal IND enabling toxicology
studies required to advance PNA5 to human clinical trials for VCID and expect to submit our IND application by
Q1 2023. Our current planned treatment protocol for VCID patients is once a day, subcutaneous 100 microg/kg
injection using a standard needle and syringe for 85 days. However, to increase patient compliance as well as
accelerate commercialization we are currently investigating new formulations that are more patient friendly and
require fewer injections. We will take advantage of Drug Delivery Experts LLC (now Pace Labs) extensive
experience in the formulation of poly(lactic-co-glycolic acid) (PLGA) sterile injectable in-situ gel formulations and
manufacturing expertise to complete the 2 principal objectives of this project.
Objective 1: Complete formulation development and scale up batch manufacturing of our extended-
release in-situ gel injection formulation of PNA5.
Objective 2. Complete in vivo PK studies of the extended-release injection formulations and compare to
standard saline formulations of PNA5.
Following successful completion of these feasibility studies, in Phase II we will conduct extensive PD/PK
studies of the PNA5-PLGA formulation in our VCID animal model to establish the cognitive protective and anti-
inflammatory effects of PNA5-PLGA and begin formal toxicology IND enabling studies.

Public health relevance
Resource Data Sharing Plan Plan for Intellectual Property and Sharing of Research Resources Intellectual property and data generated under this project will be administered in accordance with NIH policies, including the NIH Data Sharing Policy and Implementation Guidance of March 5, 2003. Ownership of sole or joint inventions developed under the project will be owned by the institution(s) employing the inventor(s). Inventors shall be determined by U.S. Patent law, Title 35 SC. Participating investigators/institutions will disclose any inventions developed under the project and such inventions will be reported and managed as provided by NIH policies. Sole inventions will be administered by the institution employing the inventor. Joint inventions shall be administered based on mutual consultation between the parties. Similar procedures will be followed for copyrights. Materials generated under the project will be disseminated in accordance with Participating institutional and NIH policies. Depending on such policies, materials may be transferred to others under the terms of a material transfer agreement. Access to databases and associated software tools generated under the project will be available for educational, research and non-profit purposes. Such access will be provided using web-based applications, as appropriate. Publication of data shall occur during the project, if appropriate, or at the end of the project, consistent with normal scientific practices. Research data which documents, supports and validates research findings will be made available after the main findings from the final research data set have been accepted for publication. Such research data will be redacted to prevent the disclosure of personal identifiers.